Investigating the crosstalk between DNA damage and innate immune signaling networks in macrophages

PROJECT SUMMARY
Innate immune cells sense and respond to bacterial pathogens through pattern recognition receptors (PRRs)
that recognize pathogen-associated molecular patterns. Coordinated responses to the infection depend on the
integration of multiple signaling networks that drive innate immune transcriptional responses. In macrophages,
a critical innate immune cell type that is among the first to respond to invading bacteria, signaling downstream
of PRRs leads to activation of key transcription factor nuclear factor kappa B (NF-κB), which drives the production
of numerous pro-inflammatory mediators that shape the immune response to infection. Among these mediators
are reactive oxygen and nitrogen intermediates (ROI/RNI) that eradicate or disable bacterial pathogens. These
intermediates are highly genotoxic, however, and can therefore also cause injury to host cells. As such, we
recently established that RNI produced during bacterial infection induce DNA double-strand breaks (DSBs) in
macrophage genomic DNA. These DSBs activate a multifactorial DNA damage response (DDR) that regulates
macrophage transcriptional responses during infection with intracellular bacterium Listeria monocytogenes
(L.m.). Notably, both PRR and DDR signaling lead to NF-κB activation through regulatory protein NF-κB essential
modulator, or NEMO. Following DNA injury, NEMO is post-translationally modified (PTM) in the nucleus.
Importantly, these PTMs are unique to NF-κB activation elicited by DNA damage. Potential crosstalk between
extracellular (e.g. PRR) and intracellular (e.g. DNA damage) signals, converging on NF-κB activation, has not
been substantively investigated and thus, is a key knowledge gap. We find that in L.m.-infected macrophages,
DDR kinase DNA-PKcs regulates the expression of several genes that are known NF-κB transcriptional targets.
Thus, we hypothesize that during bacterial infection, NF-κB activity is modulated by both DNA damage-induced
DNA-PKcs signaling and PRR signaling in macrophages to synergistically drive L.m.-elicited transcriptional
responses. To test this, we will investigate the impact of DNA-PKcs deficiency on NF-κB activity and global
chromatin binding during infection with L.m. Using a NEMO mutant that cannot be phosphorylated downstream
of DNA damage, we will then determine the impact of inactivating DDR-induced NF-κB activation on macrophage
transcriptional responses during L.m. infection. Aberrant NF-κB activity can lead to a range of human
pathologies, from immunodeficiency to hyperinflammation to cancer. Indeed, NF-κB activation downstream of
DNA injury specifically is known to be a driver of various neoplasms. Thus, a substantive understanding of the
interaction among multiple signaling pathways that converge on NF-κB activation will inform the design of rational
therapeutics to combat pathologies caused by dysregulated NF-κB activity.

Public health relevance
PROJECT NARRATIVE Communication among signaling networks is critical for driving innate immune responses during bacterial infection. Our recent work established that in macrophages, critical first responders to bacterial pathogens, DNA damage signaling regulates transcriptional responses during infection with Listeria monocytogenes. Here we will determine the molecular mechanisms by which DNA damage and innate immune signaling intersect in the activation of key transcription factor NF-κB; this work will yield unique insight into host-pathogen dynamics and will inform the design of rational therapeutics to effectively combat disorders stemming from dysregulated NF- κB activity.